ShEEP Request for MERSCOPE Instrument

Technological advances have now greatly expanded the frontier of single cell
transcriptomics. We can now measure individual cells within their spatial context and
directly observe cell-cell interactions. A leading technology in this area, named
MERFISH, uses digital barcoding of mRNAs in the cell to measure gene expression at
sub-cellular resolution. We propose to request the MERSCOPE instrument, which
allows for MERFISH processing of hundreds of genes on tumor and tissue sections to
advance our studies of cancer and other diseases that affect Veterans’ health.
In situ hybridization (ISH)-based methods entail a process whereby a target sequence is
detected by hybridization of a complementary fluorescent probe. The addition of
sequential rounds of hybridization and imaging combined with barcoding have enabled
substantial multiplexing.
In multiplexed error-robust fluorescence ISH (MERFISH), successive rounds of
hybridizations are imaged to detect the presence or absence of fluorescently labelled
probes. The serial images are then decoded, using the error-robust barcode associated
with each transcript identity. MERFISH has been used over a wide range of scales, from
transcript location within individual cells to tissue-level spatial transcriptomics.
Research projects advancing studies of diseases highly relevant to the Veterans’
community that will be supported by this instrument include studies focusing on cancers
such as prostate and lung cancer, brain diseases, such as traumatic brain injury (TBI),
frontotemporal dementia (FTD), and lung diseases.
Spatial transcriptomics is required to simultaneously image multiple cells in affected
tissues to determine cellular localization and gene expression. Lung transplant and
pulmonary fibrosis studies will be served by this equipment to image specific cell types
in lung transplant and fibrotic tissues. Infectious disease research projects related to
HIV and SARS-CoV-2 will be able to utilize this instrument to better understand the
pathogenic mechanisms of infection and persistence in tissues. Studies of prostate,
hepatocellular, and lung cancer will also utilize this equipment to characterize
prognostic biomarkers and understand the tumor microenvironment.
We are excited to request the MERSCOPE, a state-of-the-art spatial transcriptomics
instrument that will provide innovative and outstanding images for research studies to
advance Veterans’ health.
We anticipate the MERSCOPE to provide services essential towards accomplishing
VA’s research goals to understand and treat diseases of high importance to the Veteran
population.

Public health relevance
The long-term objectives of this application are to provide an outstanding and innovative high-resolution imaging resource for the current and future Veteran’s Affairs research community, which will lead to advancements in the diagnosis and treatments for diseases and conditions that disproportionately affect Veteran’s health. Current and future funded Veteran’s Affairs research projects will require and benefit from spatial transcriptomics services provided by the SFVA Urology Research Laboratory Facility. The requested MERSCOPE instrument will service research projects that are advancing studies in disease areas highly relevant to Veterans, including prostate cancer, traumatic brain injury, lung transplant, lung injury, infectious disease, dementia, and COVID-19. We request a state-of-the-art spatial transcriptomics instrument to advance the research projects of the VA. Our broad goal is to provide outstanding spatial transcriptomics capacity with functional, cost-effective, and efficient equipment.